The role of central amygdala somatostatin signaling in binge ethanol drinking

PROJECT SUMMARY
Binge ethanol consumption is the most common form of alcohol intake and represents over three-quarters of the
financial burden associated with alcohol use in the United States. In addition to associated negative health effects
such as heart disease and diabetes, binge intake is a significant risk factor for the development of alcohol
dependence, is a widespread public health concern. Despite this, there are limited treatment options available
for binge drinking or alcohol use disorders as a whole. Stress-related neuropeptides in the central amygdala
(CeA) have emerged as important targets for development of novel pharmacotherapies, however the role of one
of the most densely expressed ‘anti-stress’ neuropeptides within the brain, somatostatin (SST), in binge drinking
behavior has gone essentially neglected. This omission is of particular note as SST is well known as both a
neuromodulator and a neurotrophic factor, allowing it to alter CeA activity by direct interactions with neurons and
indirectly through modulating astrocytic activity. I hypothesize binge-ethanol intake will dysregulate SST
receptors expressed on both neural and astrocytic populations and, further, that astrocyte modulation of
inhibitory transmission on to SST-expressing cells will likewise be dysregulated, resulting in decreased ability of
this important ‘anti-stress’ peptide to regulate CeA activity. These dysregulations would be perfectly poised to
significantly contribute to the well-established increase in CeA activity known to occur during alcohol
dependence. Dissecting binge-ethanol induced alterations in CeA SST system expression and function in non-
dependent animals will therefore enable both discovery of novel treatments for this risky pattern of intake and
provide important insights into initial ethanol-induced alterations of a region critically involved in the development
and maintenance of alcohol dependence.
The K00 phase of these proposed studies employ 1) cutting-edged analysis of astrocyte morphology (using
training in immunohistochemical and confocal microscopy techniques) to characterize ethanol-induced changes
in SST receptor expression on astrocytic and neuronal populations in the CeA, as well as changes in overall
astrocyte morphology and expression of the astroglial perisynaptic sheath at synapses onto SST-containing
neurons; and 2) use of ex vivo whole cell patch-clamp electrophysiology to assess alterations in GABAergic
transmission on to SST-expressing cells, and changes in astrocyte modulation of this transmission (using training
in duel-patching technique to silence astrocyte activity). The R00 phase of the proposed studies will use these
techniques in combination with my existing expertise in chemogenetic technology and behavioral pharmacology
to 1) assess the role of the SST-expressing CeA neuron to bed nucleus of the stria terminalis (BNST) projection
in binge-drinking behavior; and 2) assess binge-ethanol induced changes in SST receptor expression within the
BNST and BNST astrocyte modulation of CeA SST terminal activity within the BNST.

Public health relevance
PROJECT NARRATIVE Binge-like and excessive alcohol consumption are major health concerns, as these types of behaviors can lead to a host of adverse health consequences including the development of alcoholism. Repeated exposure to alcohol causes changes in signaling mechanisms of key stress-related regions in the brain, altering the neurobiological response to alcohol and contributing to the transition to alcohol dependence. The present work is designed to characterize the role of a potential therapeutic target, the somatostatin system within the extended amygdala, in binge-like ethanol consumption to determine whether this system modulates this dangerous drinking pattern of drinking in a mouse model of binge alcohol consumption.